MacMillan: Coordination and Dissemination; Center for High-Throughput Functional Annotation of Natural Products: Coordination and Dissemination (Macmillian)

Abstract: The Center for High-Throughput Functional Annotation of Natural Products has been assemble to unite the data generation, data analytics and informatics strengths in the field of natural products from UTSW and UCSC to help produce a broad-scale molecular and chemical annotation botanicals and natural products. The Center is based on orthogonal phenotypic screening platforms that generate functional signatures for compounds, extracts and fractions. Our deliverable will be a data and data analytics pipeline that will help define the mechanism(s) of action of botanicals and natural products and help indicate potential therapeutic applications for novel natural product- derived chemical compounds. These data research platforms require a high level of intra-network coordination, integration with the greater botanical and natural product community, and with consumers of botanical and dietary supplements. The coordination and dissemination portion of the proposal, in conjunction with the administrative core is responsible for integration of the scientific team and a timely release of data. The intra- network coordination will be managed through monthly and yearly meetings that involve our Technology Demonstration Project collaborators and an External Advisory Board and the establishment of web-based searchable database. Integration of our Center with the botanical and natural product communities as well as botanical consumers will be driven by a highly dynamic website that provides access to our primary data, analysis and summaries of the chemical entities we evaluate.

Public health relevance
Relevance: The overarching goal of this CANPIT proposal is use innovative phenotypic screening approaches to identify the mechanisms of action of botanicals and natural products. As the use of botanicals and dietary supplements continues to rise in the United States we still have relatively little understanding of the molecular basis of how these extracts and compounds work. This has profound implications on the efficacy and safety of these products. The approaches described as part of our center will provide a molecular understanding for a large number of botanicals and natural products. Through our data coordination and dissemination component, the results from our studies will be available to the greater scientific community and consumers of botanical and dietary supplements.